Health Disparities in the Development, Persistence, and Progression of Uveitis and Ocular Inflammation in the United States

PROJECT SUMMARY
Uveitis is an important cause of visual morbidity, responsible for an estimated 10% of blindness in the United
States with an annual associated cost of $242.6 million. Prior studies have sought to elucidate the incidence
and prevalence of uveitis; however, these studies have been limited in scope by age subset, localized
geography, referral practice setting, or specialized health systems environment. The primary objectives of this
K23 career development proposal are: 1) to demonstrate the benefit of using multiple databases to
characterize the epidemiology of uveitis across the U.S., elucidating disparities in risk factors for its
development, persistence, and progression; and 2) to provide an academic uveitis and vitreoretinal surgeon
with the training and mentored research experience necessary to conduct independent clinical research.
Achieving these objectives will provide critical skills and experiences necessary to establish an independent
research program focused on applying clinical informatics to improve the clinical care of patients with uveitis.
The proposed K23 application will provide additional training in four vital areas: 1) epidemiology and
mechanisms of chronic disease; 2) quantitative characterization of health economics and health disparities; 3)
biostatistical methods for health services research; 4) validation and analysis of very large clinical databases.
The proposed research will capitalize on the strengths of two unique databases containing large and diverse
cohorts of patients, including health claims-based data from the Optum Clinformatics Data Mart and electronic
medical record-derived data from the Los Angeles County Department of Health Services safety net healthcare
system, to generate exploratory knowledge on health disparities in the epidemiology and treatment of ocular
inflammatory diseases. After validating longitudinal samples of patients with uveitis, the prevalence of uveitis in
diverse populations will be estimated, documenting race-ethnic and other disparities. Risk factors for the
development of uveitis and its sequelae will be incorporated in developing and testing models to investigate to
what degree risk factors might affect health disparities. The interaction between race and smoking status will
be a particular factor of interest. Population-based treatment patterns and health care costs associated with
non-infectious uveitis will be characterized. Socioeconomic disparities in the utilization of steroid-sparing
immunomodulatory therapy will be explored. The results of the proposed research will provide the foundation
for a future longitudinal study examining the benefit of targeted interventions in patients at higher risk of
blindness from uveitis. The ultimate goal of my research is to develop risk-stratification and treatment protocols
that guide the standardized care of patients with uveitis and decrease the incidence of ocular inflammatory
disease and its associated ocular morbidity.

Public health relevance
PROJECT NARRATIVE Ocular inflammatory disease represents an important and disproportionate cause of visual morbidity, yet real- world data to inform appropriate health policy regarding disparities in its development, progression, treatment patterns, and economics are lacking. Indeed, the restricted scope of prior case series and population studies render the epidemiology of uveitis to be poorly understood, particularly for vulnerable populations in the healthcare safety net setting. This project seeks to leverage the strengths of two unique databases, a national medical claims database and electronic medical record data from our local healthcare safety net, which contain large and diverse cohorts of patients, to explore health disparities in the development, progression, and treatment of ocular inflammatory diseases – a foundational step in innovating targeted interventions to mitigate these disparities.